Clinical-Virology Core

CLINICAL AND VIROLOGY CORE: SUMMARY
The Clinical and Virology Core (CVC) of the U54 will continue and expand recruitment of clinical cohorts of
COVID-19 patients with increased proportions of populations at risk for severe disease and medically
underserved. The CVC will provide state-of-the-art biospecimen support for Projects 1- 3 and clinical and assay
data to the Administrative/Data Analysis Core. The CVC will also oversee personnel and procedures to
implement and manage the clinical cohorts, and serve as the hub from which all Projects will obtain high-quality
deidentified clinical and virologic data, and optimally preserved patient specimens from each patient. In addition,
the CVC will be a focus of new immunological and virology assay development, with the goal (and established
track record) of rapid translation to implementation in CLIA-regulated Clinical Laboratories.